Mapping human brain cell type-specific isoform usage in ASD

Psychiatric disorders such as autism spectrum disorder (ASD) affect millions of individuals and their families
worldwide. Genetic risk plays an important role in the etiology of ASD, and we have shown that changes in brain
mRNA expression at the isoform-level, rather than overall changes in gene expression, show the largest effect
sizes and genetic enrichments. However, the extent of isoform diversity in brain, and its dysregulation in
disorders such as ASD, is vastly underexplored because many isoforms cannot be resolved at the cell type-level
by commonly used short-read RNAseq technologies and are yet to be directly profiled. Thus, there is an urgent
need to assess the role of isoform expression and its relation to ASD-associated genetic variation − with precise
cell-type and spatial specificity to understand the neurobiological mechanisms through which it confers disease
risk. Our goal is to address these and other deficits in our understanding of the landscape of isoform expression
in neurotypical and diseased brain. As such, we will use long-read RNA isoform sequencing to generate isoform
maps and characterize the structure, expression abundance and usage of full-length isoforms in 3 brain regions
implicated in ASD. We will further complement by deeply profiling 50 high-confidence ASD risk genes with
evidence of isoform dysregulation, to identify isoform expression patterns at the cellular level.
In Aim 1 we will perform whole-transcriptome full-length (FL) RNA isoform sequencing (IsoSeq) of postmortem
hippocampus (HC) and striatum (STR) brain tissues of ASD cases and neurotypical controls, and combine the
data with our existing data for prefrontal cortex (PFC) to construct a comprehensive map of isoform expression
across the 3 brain regions. Notably, we will also use our reference maps of normal and dysregulated full-length
isoform expression as priors for analyses of a compendium of >2,000 RNAseq datasets from ASD cases and
controls amassed by the PsychENCODE consortium and other efforts, and identify dysregulated isoforms and
isoform co-expression network modules. In Aim 2 we will use a complementary approach to profile single-nuclei
of the same PFC, HC and STR tissues in ASD and controls to disambiguate isoform expression differences of
50 ASD risk genes at the cell-type level using 10X snIsoSeqCap, which is a novel assay to sequence FL-
transcripts of selected genes across their entire length at the single nucleus/cell level. We will perform integrative
analyses to identify isoform expression differences between tissues and cell types, and selected isoform changes
will be validated by RNA fluorescent in situ hybridization (FISH) and quantitative isoform-specific PCR in selected
neuronal and non-neuronal cell types.
The maps generated here will improve existing reference genome annotations, and allow to address major
outstanding questions regarding isoform expression in human brain. The new data and methodologies will
provide a tremendous resource for the neuroscience community, paving the way to better inform neurobiological
mechanisms of genetic risk for ASD.

Public health relevance
PROJECT NARRATIVE Isoform expression in brain and its dysregulation in autism spectrum disorder (ASD) remains vastly underexplored in part because many isoforms are yet to be directly profiled or annotated, and many cannot be reconstructed based on short-read RNA-seq data alone. Here we will generate a map of full-length, tissue- and cell type-specific, isoform diversity in human brain to understand its impact in transcriptional regulation in ASD, with application to other brain disorders.